REGULATION AND ACTION OF THYROTROPIN

The human thyrotropin (TSH) receptor has not previously been purified or characterized. This receptor is nor only important for its interaction with thyrotropin, but also for its interaction with thyroid-stimulating antibodies in Graves' Disease (a major cause of hyperthyroidism), as well as thyroid-blocking antibodies in idiopathic hypothyroidism. Using recombinant DNA methodology and monoclonal antibodies to the TSH receptor we have isolated several cDNA clones as well a 2 variant genes coding for a TSH receptor. This receptor shows specific binding to TSH as well as both stimulating and blocking antibodies. It has 7 membrane spanning domains analogous to several other polypeptide hormone receptors coupled to guanine nucleotide binding proteins. Enzymatic deglycosylation of TSH has been achieved by newly available endoglycosidase F preparations. The deglycosylated molecule shows decreased in vivo and in vitro bioactivity.